Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administrative Core will provide support for the research, training, community engagement, data
management, and information and technology transfer in this Superfund Research Center (SRC). Core
leadership is provided by the Program Director/Principal Investigator, Dr. Norbert Kaminski. The Core will be
located within the offices of the Institute for Integrative Toxicology at Michigan State University, a unit
coordinating campus-wide multidisciplinary activities in environmental and molecular toxicology. The Principal
Investigator is Director of the Institute. Staff for the Administrative Core includes a part-time
accountant/administrator, a part-time secretary and a part-time communications specialist. The PD/PI will
provide administrative and scientific leadership of the research program with input from an Internal and an
External Advisory Committee. The Core will organize and support regularly scheduled meetings and video-
conferencing for exchange of research and administrative information among the entire research group. It will
prepare progress reports and other information that is required by the NIEHS Superfund Research Program
(SRP) administration. Fiscal responsibilities attributed to the Core will include management and dissemination
of funds to research projects and cores, monitoring of expenditures, and communication and reporting as
required by NIEHS fiscal administration personnel. The Core will take leadership in and organize activities
involving communication with government officials and personnel regarding the research program. Dr. Brad
Upham will coordinate the Research Translation activities. Communications required for Research
Translation, including information and technology transfer, will be led and coordinated through Core activities,
including, face-to-face meetings with local, state and federal officials, updating of website information
concerning research progress. A Pilot Project Program supported by non-NIH funds principally from
institutional support will be used for initiation of new research projects will also be administered by the Core.

Public health relevance
PROJECT NARRATIVE The Administrative Core provides support for the research, training, community engagement, data management and information and technology transfer in this Center Program. The Core will take leadership for regular communication with Center investigators and NIEHS for exchange of information, prepare progress reports, fiscal responsibility, technology transfer and communication with stakeholders in government, academia and industry regarding the research program.